A microphysiological system of tendon inflammation and fibrosis for drug screening and efficacy testing

Acute and chronic tendon injuries are among the most common musculoskeletal health problems. Typically, an
injured tendon experiences fibrotic scarring that leaves the tissue mechanically compromised and prone to
debilitating adhesions that impair joint function. In a fibrotic tendon scar, the cell-cell and paracrine signaling
between inflammatory cells, such as macrophages, and tendon fibroblasts activate the latter into
fibroproliferative myofibroblasts, ultimately differentiating into a senescent phenotype. Our previous studies
using next-generation sequencing and gene set enrichment analysis mechanistically linked fibrosis and
senescence in injured mouse tendons with TGF-beta activated mTOR signaling. To further elucidate this
pathology, the goal of this proposal is to engineer a microfluidic human tendon-on-chip (hToC) system and use
it to more accurately model the biological aspects of the inflammation and fibrosis in injured tendons. In the
UG3 phase of this proposal, the chip will be fabricated featuring a multicompartmental design and microfluidic
channels to incorporate a fibroblast-seeded collagen hydrogel and simulate vascular blood flow, respectively.
Ultrathin, highly permeable, and optically transparent porous silicon membranes (SiM) will separate the
hydrogel from circulation and provide a substrate for an endothelial barrier in between. The signaling between
the fibroblasts, hydrogel-resident- and circulating-macrophages, and endothelial cells will be enabled through
nanoporous SiM (~60 nm), while a microporous SiM (~ 8 µm) will allow extravasation of circulating
macrophages and infiltration of the hydrogel under TGF-beta stimulation. To allow for a patient-centric chip,
tendon fibroblasts will be used to create the tendon hydrogel and to reprogram donor-matching iPSCs to derive
the endothelial cells and macrophages, respectively. An additional innovation will be the integration of label-
free photonic sensors into the microfluidic device to allow on-chip sensing, which has been long appreciated as
a critical, unmet need for organ-on-chip devices. The UG3 studies will use the chip to validate the role of
mTOR in the disease model and identify biologically relevant biomarkers. In the UH3 phase, we will utilize the
chip as a pre-clinical trial platform for testing efficacy and safety of FDA-approved mTOR inhibitors as potential
disease modifying drugs, and as a drug screening platform to identify and prioritize safer and more potent
inhibitors of mTOR and senescence in tendon injury for clinical trials. To successfully complete this innovative
project, we have assembled a team of accomplished experts in tendon tissue engineering and surgery,
immunology, iPSC technology, GMP cell manufacturing, nano- and micro-fabrication, sensor technology, and
high throughput screening. The proposed studies will develop a human microphysiological system to catalyze
clinical trials and accelerate drug discovery for acute and chronic tendon injuries.

Public health relevance
Second only to joint replacement and spinal fusion surgeries, procedures to repair tendon and other soft connective tissues represent ~20% (~2.5 million) of all major musculoskeletal procedures. The incomplete understanding of the complex cellular and molecular processes in tendon injury has hindered the development of biological therapies for regenerative tendon repair. This proposal develops a human microphysiological system to elucidate the roles of inflammation and fibrosis in this pathology and enable evaluation of safety and efficacy of disease-modifying treatments to inform clinical trials.